GLUCOSE METABOLISM AFTER MIXED MEAL INGESTION IN DIABETICS AND NORMALS

The purpose of this study is to examine the changes in glucose absorption, hepatic glucose production, and glucose utilization after the ingestion of a mixed meal in patients with diabetes mellitus and healthy control subjects.